Central Coordinating Site for the Polycystic Kidney Disease (PKD) Research Core Centers

Polycystic Kidney Disease (PKD) is the leading inherited cause of renal failure globally yet there are no therapies to reverse or cure it. Over recent decades, the genes responsible for the most frequent forms of PKD (PKD1, PKD2 and PKHD1) have been identified. Progress over this time has led to improved cell-based systems, the generation of faithful animal models and new imaging biomarkers for human ADPKD, which have enabled clinical trials. Despite these advances gaps remain in our understanding of how primary gene mutations disrupt cellular pathways. It has become clear that it will take a multidisciplinary approach to unravel the complexities of PKD gene loss. The NIDDK has sought to support innovation in PKD research by establishing the Polycystic Kidney Disease Research Resource Consortium (PKD RRC), which created a framework for developing and sharing resources and core services. Over the past 5 years our team has led the PKD RRC Central Coordinating Site (CCS), developing a robust platform to support the consortium’s administrative and research needs. Building on this foundation we will continue to strengthen the PKD RRC as a central hub for research resources, collaboration, innovation and education in PKD. Our mission is to energize PKD research by fostering data driven science and by renewing a focus on resource development and expansion of the PKD research ecosystem. Leadership of the Central Coordinating Site will continue to be provided by Drs. Watnick and Somlo, two senior investigators with deep expertise in the PKD field and a commitment to collaborative science. The CCS will support the PKD RRC with the following Specific Aims: 1) Coordinate consortium operations to achieve synergy and cooperation among PKD Core Centers; 2) Support a national PKD research effort by sharing existing and newly developed research resources; 3) Implement a multipronged communication plan to disseminate information about research resources, funding opportunities and educational events; 4) Implement educational programs that encourage constructive discourse, foster innovative approaches to PKD science and enhance the visibility of the PKD RRC; 5) Administer a National Pilot and Feasibility Program that will target early-stage investigators and innovative projects in areas of priority to the PKD RRC and 6) Implement a consortium-wide Plan for Incorporating Patient Perspectives in the work of the PKD RRC In summary, the CCS will foster a collaborative and innovative environment that will accelerate research in PKD.

Public health relevance
Polycystic Kidney Disease (PKD) is the leading inherited cause of renal failure globally, yet there are no therapies that can reverse or cure this disorder. To accelerate discovery, the NIH launched the PKD Research Resource Consortium (PKD RRC) which provided a framework for collaboration and resource sharing. This proposal aims to establish a Central Coordinating Site that will support the consortium’s administrative needs and serve as a hub for research sharing, community building, resource development, innovation and education in the field of PKD.